Defining and Characterizing Drivers of Lethal Metastatic Prostate Cancer

Prostate cancer (PC) is the second leading cause of cancer-related deaths in the USA. The goal of our
proposed research is to identify genetic factors that are essential for the switch from indolent to lethal
metastatic prostate cancer. We have generated primary cell lines from tumor and metastasis of the RapidCaP
mouse model for lethal PC (PTEN and TP53 deficient). Our preliminary data highlights a fundamental shift
in cellular phenotype and growth signaling associated with the transition to metastasis. Most importantly, the
loss of TAM kinase receptor is key for this metastasis associated cellular reprogramming event. These
discrete cellular states are associated with divergent signaling behavior, which enables or restricts the
metastatic potential of cancer cells. Therefore, our focus is now on delineating the role of TAM kinases in PC
metastasis and the signaling cascade controlling the switch from primary to distant metastatic disease in
vivo. In this proposal we will mechanistically validate the role of TAM receptors in PC cellular lineage
reprogramming and maintenance of pro-metastatic EMT-like phenotype (Aims 1 and 3). Next, we will assess
the role of PI3K/mTOR signaling axis in TAM-deficient PC (Aim 2). To execute the proposed aims, we will
closely collaborate with experts in receptor signaling and prostate cancer disease biology. Our background
in mouse genetics, cell biology and translational oncology is well aligned with the expertise required to carry
out the proposed work and unravel the genetic dependencies of lethal metastatic PC cells.

Public health relevance
Prostate cancer (PC) is a slow growing disease, curable if detected early and the cancer is within the tissue of origin. Paradoxically the most lethal form of PC is the fast growing and quickly spreading type. This proposal will employ rigorous functional genetics tools and in-vivo models to obtain mechanistic insights. We will identify the genetic addictions of metastatic PC cells and discover effective therapies against the cellular switch to lethal metastatic disease.